Administrative supplement for the flow cytometry cell sorter purchase

The COBRE Center for Targeted Therapeutics (CTT) at the University of South Carolina (UofSC) supports
research that seeks to develop new and more effective classes of drugs against various diseases, by aiming
these drugs at molecular and cellular targets that play a key role in the disease. FACS is a powerful method to
collect and analyze various populations of cells after a drug treatment. Importantly, the cells can be from
dissociated tissue or blood from animal models. The sorted populations can then be subjected to further
analysis, such as gene expression or immune cell marker classification. The existing cell sorter in the CTT
Microscopy and Flow Cytometry Core (MFCC) has been in service for 19 years and has several limitations
relative to more modern instrumentation. It is difficult to change the source of input cells without causing
contamination, and samples from dissociated almost always contaminates the instrument. Decontamination is
difficult and is weakening the old fluidics system. The purpose of this proposal is to acquire funds to purchase a
Sony SH800 Cell Sorter. This instrument uses disposable microfluids chips to eliminate the cross-contamination
problem experienced with the older instrument. Also, it is much easier to operate and sorts cells faster compared
to the previous generation. There are several investigators who have already expressed their support for this
application. Their applications include characterizing infiltrating immune cells in an animal model of breast
cancer; sorting cells from developing zebrafish to understand mechanisms of craniofacial development; sorting
the microbiota and epithelial cells of colon in a mouse model of early onset colorectal cancer caused by antibiotic
treatment; and a current CTT-target project, collect hematopoietic stem cells to use in transplantation studies.
The addition of this instrument to the MFCC will expand the capability of the core and help the CTT to achieve
its goals to provide needed resources to investigators developing targeted therapeutics.

Public health relevance
PROJECT NARRATIVE The University of South Carolina Center for Targeted Therapeutics promotes the discovery of new molecular targets in human diseases and the development of drugs specific to those targets. This application is for an administrative supplement to fund the acquisition of a cell sorter to be used for sorting and analyzing cells dissociated from animal disease models and samples from a wide variety of species. The instrument will help the Center to extend its range of support of drug discovery investigators.